Mechanisms for recruitment and function of metazoan replication initiation factors

Project Summary
The survival of living organisms depends on the timely and accurate duplication of chromosomal DNA. In all
domains of life, the onset of DNA replication (or initiation) relies on dedicated initiator proteins that bind
genomic sites, termed replication origins, and help load replicative helicases onto DNA. In eukaryotes, the
initiator is the origin recognition complex (ORC), which recruits and deposits the Mcm2-7 helicase motor
module onto DNA to ‘license’ origins. Although core replication initiation factors are conserved across most
eukaryotes and are well-studied in budding yeast, important differences exist with respect to origin recognition
and the regulation of origin licensing between S. cerevisiae and higher eukaryotes. Numerous outstanding
questions therefore remain in the metazoan system regarding origin recruitment and function of core and
accessory DNA replication initiation factors, and the specific contributions of chromatin-associated proteins to
these events. In this proposal, we aim to define at a mechanistic level in metazoan systems how ORC-
dependent DNA remodeling contributes to Mcm2-7 loading, how disease-linked mutations alter initiator
activities, and how ORC-partner proteins promote chromosomal recruitment and function of the initiator, by
integrating biochemical, structural, and cell-based approaches. The findings from this work will have broad
implications for multiple scientific fields, as they will not only help generate models for origin specification,
origin processing, and origin licensing in metazoans, but also contribute to our understanding of DNA- and
chromatin-dependent macromolecular machines. Our studies are also of significant biomedical relevance since
the failure to precisely replicate chromosomal DNA causes genome instability, which in turn underpins many
human diseases, including cancer. In the long-term, the outcomes of our efforts thus have the potential to
provide important starting points for the development of novel therapeutic strategies.

Public health relevance
Project Narrative The correct duplication of genetic information encoded in DNA is essential for cell growth and survival, and dysregulation of this process is linked to human diseases such as cancer. This proposal aims at uncovering mechanisms that control DNA replication onset in multicellular organisms at a molecular and structural level. The knowledge gained from this work will be important for advancing our understanding of disease mechanisms related to DNA replication and for developing novel therapeutic strategies.